Brd4 is an atypical kinase that regulates transcription

Despite the interest in BRD4, there is relatively little understanding of its global functions or its structure. BRD4 is a protein of 1362 amino acids in humans and 1400 amino acids in mice. The N-terminal half of the molecule encodes two bromodomains that bind to acetylated lysines. One of the major targets for BRD4 binding is to acetylated histones which results in the recruitment of a variety of transcription factors to regions of active chromatin, including super-enhancers and typical enhancers. BRD4 also plays a direct role in regulating transcription, mediating pause release through its atypical kinase activity which we discovered. As part of the transcription initiation complex at the promoter, BRD4 phosphorylates the Pol II carboxy-terminal domain at Ser-2 and activates Topoismerase I that is required to relieve the torsional stress caused by Pol II synthesis, both required for pause release. Relatively little is known about the biophysical properties of BRD4. Structural analysis has only been achieved for the two bromodomains and ET domain. Computational modeling of BRD4's secondary structure predicts that the amino-terminal half of the molecule is highly ordered whereas the carboxy terminal half is extensively intrinsically disordered. The goal of our studies is to further characterize the mechanisms by which BRD4 regulates transcription through characterizing its biophysical, biochemical and structural properties. Analysis of its elution during size exclusion chromatography (SEC) led to the surprising finding that purified recombinant BRD4 eluted in a peak corresponding to a molecular weight of 900kD. These findings were particularly surprising in light of our observation that BRD4 migrates as a single band with a molecular weight of 156kD in denaturing gels, as would be expected of a molecule of 1400 aa. To further characterize the conformation of BRD4 in solution, we performed sedimentation velocity experiments using analytical ultracentrifugation (AUC). The results of these analyses were most consistent with a dimeric state. Recent differential scanning fluorimetry studies confirmed that BRD4 exists as a dimer in solution. The site of dimerization of BRD4 has been mapped to a segment between 503-534, the B domain. Deletion of the B domain abrogates dimerization. As noted above, BRD4 phosphorylates the CTD of RNA polymerase II, which consists of 52 repeats of the heptad YSPTSPS. It plays a critical role in regulating transcription initiation and elongation through the differential phosphorylation of its serine, threonine, and tyrosine residues by multiple kinases, including BRD4. Although we had demonstrated the phosphorylation of Ser2 of the CTD, we have not previously shown a stable interaction between BRD4 and the CTD. Therefore, we undertook to determine by AUC the stoichiometry and affinity of interaction between BRD4 and purified CTD1-52 in solution. Our results clearly document a direct interaction between BRD4 and CTD, albeit of low affinity and driven by concentration. We have previously described BRD4 as an atypical kinase with kinase subdomains distributed across the N-terminus. Mutation of one, or even a few, of the kinase domains does not completely inhibit its kinase activity. To assess the kinetics of trans-phosphorylation, we examined two of BRD4's substrates, the CTD and TAF7. Phosphorylation of the Pol II CTD occurred with a Km of 259 nM. The observation of a low to intermediate affinity of interaction is consistent with the findings by AUC. Phosphorylation of TAF7 by BRD4 occurred with a significantly lower Km of 49.7 nM, indicative of a higher affinity of interaction. Both followed classical Michaelis-Menten kinetics. Similarly, BRD4 hydrolyzed ATP efficiently with a Km of 37.6 nM+6.8nM, as assessed by the extent of autophosphorylation and following classical enzyme kinetics. These results establish that despite the atypical patterns of kinase subdomains, BRD4 kinase activity follows classical Michaelis-Menten enzyme kinetics. To further characterize the BRD4 kinase activity, we generated a series of truncation and deletion mutants. Deletion of the N-terminal half of BRD4 (1-722) abrogated kinase activity whereas truncation of the C-terminal half (730-1400) retained kinase activity. In addition to two bromodomains, the salient domains within the 1-722 region are the A motif, B motif, BID domain, ET and SEED domains. Deletions of the ET and SEED domains retained kinase activity, as did a fragment extending from 1-600 aa. To further map the kinase activity, we generated a BRD4 mutant deleted of the segment 351-598 (d351-598), which is enriched in predicted kinase subdomains and spans bromodomain 2 and the B-BID domains (BD2-B-BID). Deletion of this region (d351-598) abrogated BRD4's auto and trans phosphorylation activities by 97.5%, indicating that BRD4's kinase domain is contained within the BD2-B-BID. Importantly, smaller deletions within this segment retained activity, consistent with the distributed kinase domains of an atypical kinase. To directly demonstrate that the BRD4 kinase domain is located in the 351-598aa segment, peptide fragments of BRD4 spanning the segments 275-730, 358-730 and 358-646 were generated and tested for their kinase activity. All three fragments were able to auto-phosphorylate, mapping both the kinase activity and the sites of phosphorylation within this segment. The patterns of trans-phosphorylation were markedly different using CTD or TAF7 as substrates. Only the largest fragment 275-730 could trans-phosphorylate the CTD, whereas both 275-730 and 358-730 fragments efficiently phosphorylated TAF7. Thus, the kinase activity largely resides within the 351-598 segment which spans the BD2, B and BID domains. The inability of the 358-730 fragment to phosphorylate the CTD, but not TAF7, suggests that the CTD binding site maps to the 275-358 region. In contrast, the TAF7 binding site maps to the region 358-730. The finding of different binding sites of the CTD and TAF7 on BRD4 is consistent with their observed differences in enzyme kinetics. Peptides derived from the viral MLV integrase and cellular demethylase, NSD3, which have been shown to bind to the ET domain, are also phosphorylated by BRD4. Thus, BRD4 kinase activity maps to a region between 351 and 598 aa and is capable of both autophosphorylation and trans-phosphorylation of a variety of substrates binding to various sites on the molecule. The critical role of BRD4 in regulating gene expression, its pleiotropic functions and its unusual structural organization, led us to attempt to determine its structure. The N-terminal segment of the molecule is highly ordered. However, the C-terminal half which spans both the HAT domain and the MYC-binding domain, is predicted to be intrinsically disordered. Application of AlphaFold-2 analysis to BRD4 did not generate any structural insights or predictions that could be tested experimentally. In collaboration with Dr. Sriram Subramaniam, we undertook a cryo-EM analysis of BRD4 in an effort to resolve the structure. Due to the highly disordered state of BRD4, it has not been possible to generate even low-resolution structures of BRD4 alone. Analysis of BRD4 in complex with some of its known interactors, as well as small molecule binders, hold promise for solving the structure. The structural studies of BRD4 led to the finding that native BRD4 exists as a dimer in vitro. Deletion of the 45 aa B domain results in an exclusively monomeric conformation. We observed a surprising correlation of the BRD4 conformation with kinase activity. Although the dimer and monomer display kinase activity in vitro, only the dimer is an active kinase in vivo; both conformations retain HAT activity. Current studies are underway to define the mechanistic basis for this difference.